ZOLEDRONATE PREVENTS BONE LOSS IN OVARIECTOMIZED RHESUS MONKEYS

This study evaluated the effect of Zoledronate (ZLN) on skeletal changes in ovariectomized (OVX) rhesus monkeys. Forty adult female rhesus monkeys (mean age 15.3 q 0.4) were randomly assigned to one control or four OVX groups. Three OVX groups received ZLN (0.5 ug/kg, 2.5 ug/kg, or 12.5 ug/kg) by a single weekly subcutaneous injection; the control and one OVX group received the saline vehicle (0). Dual-energy x-ray absorptiometry of the total body, lumbar spine, proximal femur, and mid and distal radius was done at 0, 13 and 26 weeks post-OVX. Serum and urine markers of skeletal turnover were measured at 0 and 13 weeks post-OVX. Data were analyzed byrepeated measures ANOVA. TBBMC Control OVX/0 OVX+0.5 OVX+2.5 OVX+12.5 0 wks 283 (10) 313 (18) 292 (15) 281 (13 288 (14) 13 wks 275 (10)* 293 (16) 276 (15) 275 (11) 290(14)a 26 wks 277 (11)a 286 (18) 272 (14) 277 (13)a 294(15)a LSBMD 0 wks .69 (.02) .74 (.03) .72 (.04) .68 (.03) .70(.03) 13 wks .70 (.02)* .69 (.02) .66 (.03) .66 (.03) .70(.03)* 26 wks .71 (.02) .70 (.02) .67 (.03) .70 (.03) .71(.04) TBBMC = total body bone mineral content (gramsqSEM)LSBMD = lumbar spine (L2-L4) bone mineral density g/cm2qSEM)Different from OVX/0 * = p < .05, = p < .005, a = p < .001. OVX-related loss was present (TBBMC and LSBMD) at 13 and 26 weeks. This loss was prevented by 12.5 and/or 2.5 ug/kg/wk ZLN but not 0.5 ug/kg/wk (Table). No OVX or ZLN treatment effect occurred at the femur or radius. At 13 weeks, serum skeletal alkaline phosphatase, osteocalcin, and urinary NTX were increased by OVX (p<.01). ZLN (2.5 and 12.5 ug/kg/wk) maintained these measures at or below control levels. In conclusion, OVX induces a 5-8% decline in TBBMC and LSBMD by 13 weeks in adult rhesus monkeys. ZLN prevents the OVX-induced bone turnover increase and bone loss. The adult rhesus monkey is a good model of estrogen-depletion bone loss. ZLN may prove to be effective in preventing postmenopausal bone loss.